Admin-Core-001

Modified Project Summary/Abstract Section
The major goal of the Mississippi Center of Excellence in Perinatal Research (CEPR) is to develop an innovative, independent and sustainable center of excellence in perinatal research and treatment spanning the spectrum from adverse pregnancy to subsequent outcomes in offspring. More specifically, perinatal research encompasses the study of disease states that may occur during gestation and early post-natal development that result in long term consequences in the mother and offspring across their lifespan. A major goal of this proposal is to develop a Research Center that will provide infrastructure and capacity for a group of basic, clinical and population scientists studying the common synergistic theme of perinatal and perinatal-derived diseases and to facilitate their collaborations.
The specific aims of the Administrative, Mentoring and Education Core A include the following:
1. To provide overall leadership for development of infrastructure, mentoring programs and research core facilities that foster excellence in perinatal research spanning the spectrum from adverse pregnancy to subsequent outcomes in offspring and will lead to development of an innovative, internationally recognized Center of Excellence.
2. To develop, implement and monitor a Mentoring and Education Program that facilitates development of investigators with no previous NIH funding into independent, extramurally (NIH) funded researchers.
3. To develop and implement a Pipeline Grants Program for investigators to obtain preliminary data for future NIH grant submissions.
4. To develop and implement educational programs that will facilitate collaborations and interactions among investigators from multiple disciplines in perinatal research at UMMC.
5. To develop and implement programs for recruiting, training, and mentoring students to provide mentoring experience for investigators, and so that the trainees become the next generation of perinatal researchers.
6. To implement formative and summative evaluation strategies for overall progress and effectiveness of the MS CEPR investigators, programs, and cores.
7. To provide high-level program administrative support and fiscal oversight of all research projects and cores.
8. To organize networking meetings and seminars related to the Center as well as meetings of the Executive Committee, Internal and External Advisory Committees.
9.To ensure that all Center programs, initiatives, policies and reporting mechanisms to UMMC and NIGMS are optimally developed, implemented, and administered within federal granting agency policies and deadlines.